The Mediational Intervention for Sensitizing Caregivers: Feasibility and Acceptability for Black and Hispanic Formerly Incarcerated Mothers

PROJECT SUMMARY/ABSTRACT
The incarceration of a mother disrupts parent-child attachment relationships, increases the risk for
psychopathology and other negative outcomes in children, and disproportionately impacts Black and Hispanic
families. Interventions that aim to repair attachment disruption and promote positive parent-child relationships
following maternal incarceration have the potential to interrupt the intergenerational transmission of
psychopathology and other negative outcomes. While there are a growing number of attachment-based
parenting programs for incarcerated mothers, they focus exclusively on infants. Additionally, most corrections-
based interventions have not been culturally adapted for ethnically or racially minoritized mothers, who face
disparities at every level of the criminal punishment system. Moreover, programs have not been tailored for
formerly incarcerated mothers despite significant parenting stress and difficulty accessing resources following
release. There is also a need to investigate the acceptability of virtual delivery that would increase scalability.
We identify the Mediational Intervention for Sensitizing Caregivers (MISC), a developmentally and culturally
transportable
video-feedback intervention
that addresses the attachment relationship and promotes evidence-
based positive parenting behaviors. The proposed project will use a mixed-methods, community-based
participatory approach to evaluate the feasibility and acceptability of MISC for Black and Hispanic formerly
incarcerated mothers and identify targets for future adaptation, including an innovative virtual delivery format,
following the first 3 steps of the evidence-based ADAPT-ITT model. Aim 1 is to assess the target population’s
characteristics and needs using quantitative methods (surveys with 120 Black and Hispanic formerly
incarcerated mothers,120 control mothers) and qualitative methods (interviews with 20 formerly incarcerated
mothers and focus groups with community advisory board members). We hypothesize that quantitative
analyses will reveal greater need for intervention among formerly incarcerated mothers and qualitative
analyses will reveal themes of parenting challenges related to incarceration and desire for support. Aim 2 is to
use Aim 1 results to evaluate the feasibility of MISC and identify initial adaptation targets by comparing the
target population’s parenting experiences and goals to the standard structure, goals, and delivery of MISC. We
hypothesize that MISC will be feasible and adaptation targets will be identified. Aim 3 is to evaluate the
acceptability of MISC through theater testing with 5 focus groups of formerly incarcerated mothers. We
hypothesize that MISC will be acceptable and that we will identify and refine additional adaptation targets. The
proposed study is in line with the NIMH’s strategic goal to prevent psychopathology and improve public health
in marginalized and underserved communities. Additionally, findings will directly inform future studies to adapt
and evaluate MISC for formerly incarcerated mothers, holding the potential to improve wellbeing in these
families. Finally, this fellowship will support the applicant’s development as an independent researcher.

Public health relevance
PROJECT NARRATIVE Maternal incarceration disrupts parent-child attachment relationships, increases the risk for mental health problems and other negative outcomes in children, and disproportionately impacts Black and Hispanic families. The goal of the current application is to use a mixed-methods, community-based approach to evaluate the feasibility and acceptability of the Mediational Intervention for Sensitizing Caregivers (MISC) for Black and Hispanic formerly incarcerated mothers and identify targets for future adaptation. This research could serve as the foundation for future studies focused on adaptation and implementation of MISC for formerly incarcerated mothers, holding the potential to interrupt the intergenerational transmission of psychopathology and improve the health and wellbeing of marginalized and underserved families.